Tailoring Diabetes Support to Social Contexts for Adults Living with Type 2 Diabetes

PROJECT SUMMARY
Among adults with type 2 diabetes (T2D), daily diabetes self-management occurs in social contexts with close
family and friends (herein, “family”). We recently developed, replicated, and longitudinally validated a typology
of diabetes-specific family functioning. We identified four conceptually distinct profiles ("types") which were
independently associated with diabetes self-management and psychological well-being, cross-sectionally and
over time. The typology is applicable across diverse family structures, replicated in racially diverse samples, can
be assessed through a survey tool, and has the potential to lead to breakthroughs in interventions for adults
with diabetes. Therefore, within our recently completed randomized controlled trial (RCT) evaluating a family-
focused mobile phone-delivered intervention we applied the typology post-hoc to explore intervention
engagement and effects by family functioning type. From these analyses, we know which types did and did not
benefit from the family-focused intervention and have developed hypotheses informed by mixed-methods
preliminary data about how to tailor the existing intervention to benefit other types. Therefore, we propose to
apply the family functioning typology proactively to inform an innovative, adaptive intervention to meet
participants' evolving needs. The proposed type-informed adaptive intervention leverages our existing
infrastructure to provide mobile phone-delivered intervention components, including: goal setting and
monitoring (via phone coaching and text message support), skill building (via phone coaching), and the option
to invite a friend or family member to participate in the intervention as a support person. These components
will be turned on/off or adapted per most recent type assessment, tailoring both intervention form (individual
vs. family) and content focus (disease vs. personal skills). We will enroll N=405 adults with T2D receiving
primary care in the mid-South in a RCT lasting 16 months, including a 12-month intervention period, with
assessments every 4 months. We aim to (1) evaluate the innovative type-informed adaptive mobile phone-
delivered intervention relative to enhanced treatment as usual on hemoglobin A1c, diabetes distress, global
well-being, diabetes self-efficacy and self-care behaviors, and (2) evaluate intervention effects for each type to
discern which types experienced clinical benefit and inform which types need different intervention
components. We will evaluate effects during the intervention, post-intervention, and sustained 4 months after
the intervention ends. This project aligns with the NIH-wide strategic plan 2021-2025 to advance research on
“giving the right treatment to the right patient at the right time” (p.12) and advances this plan through its novel
focus on (a) a behavioral intervention and (b) family context as a key tailoring variable. Moreover, the proposed
intervention is consistent with the American Diabetes Association's Standards of Care 2023 recommendation
for systems that combine automated technology and coaching to support adults with diabetes.

Public health relevance
PROJECT NARRATIVE Precision medicine approaches are urgently needed to improve self-management support for adults with type 2 diabetes. Our innovative validated typology of diabetes-specific family functioning will be applied to get the right intervention to the right person at the right time. In a randomized controlled trial, we will evaluate the benefits of an adaptive intervention - tailored over time using typology assessments and delivered via basic mobile phone technology - on participants' hemoglobin A1c, diabetes distress and global well-being.